Sex and Gender Analysis Resource Core

SEX AND AGE DIFFERENCES IN IMMUNITY TO INFLUENZA (SADII) SEX AND GENDER ANALYSIS
RESOURCE CORE SUMMARY
The SADII Sex and Gender Analysis Core will be led by Drs. Rosemary Morgan and Abdul Bachani and will
provide analytic support to the human research projects (i.e., SADII Research Projects 1 and 2) included under
the SADII SCORE. The Core will provide input into the data collection tools and approaches utilized in SADII
Research Projects 1 and 2 to better inform relevant sex and gender analysis, in addition to providing support
for both qualitative and quantitative analyses of data to examine and understand the distinct and overlapping
contributions of sex and gender, and their intersection with other social stratifiers (e.g., race), to vaccine-
induced immune responses, adverse reactions, and outcomes in young and aged adults. Specifically, we will
explore sex and gender differences in: (1) influenza vaccine acceptance (SADII Research Project 2); (2)
immune responses (SADII Research Projects 1-2); and (3) adverse reactions to vaccination (SADII Research
Projects 1-2). We will provide quantitative analysis of clinical and immunological data to explore sex
differences in vaccine-induced immune responses, including how sex intersects with other social stratifiers,
such as age, race, and frailty, to influence immune responses and outcomes following influenza vaccination.
We also will perform quantitative and qualitative data collection and analysis to explore gender differences in
vaccine acceptance, immune responses, and adverse reactions, and how gender intersects with other social
stratifiers, such as age, race, and frailty, to influence immune responses and outcomes following influenza
vaccination. Finally, we will offer analysis of the interaction of sex and gender, including how sex and gender
intersect with other social stratifiers, such as age, race, and frailty, to influence vaccine-induced immune
responses and outcomes following influenza vaccination. Exploring how sex and gender intersect with other
social stratifiers will enable us to explore differences between men and women, as well as differences among
men and women in vaccine acceptance, immune responses, and adverse reactions to vaccination. In addition
to supporting the SADII SCORE projects, the Sex and Gender Analysis Resource Core will also provide
services to public health and clinical researchers interested in sex and gender analysis of qualitative and
quantitative research, which is currently not available at Johns Hopkins.

Public health relevance
SADII SCORE SEX AND GENDER ANALYSIS RESOURCE CORE NARRATIVE The Sex and Gender Analysis Resource Core will provide analytic support and guidance to the human projects included under the Sex and Age Differences in Immunity to Influenza (SADII) SCORE. the SADII Sex and Gender Analysis Core will provide support and guidance on the collection and analysis of sex and gender data, and their intersection with other social stratifiers, such as age, race, and frailty, on vaccine-induced immune responses, adverse reactions, and outcomes in young and aged adults. Currently there is no core dedicated to sex and gender analysis of public and clinical health studies at Johns Hopkins University; therefore, in addition to supporting the SADII SCORE projects, the Sex and Gender Analysis Core will also provide services to public health and clinical researchers interested in sex and gender analysis of qualitative and quantitative research, which is currently not available at Johns Hopkins.